Determining the mechanisms of vascular CD8 T cell activation in CMV and HIV infections

PROJECT SUMMARY/ABSTRACT
Persons living with HIV infection (PWH) on antiretroviral therapy (ART) are succumbing earlier to many of the
same complications that plague the HIV-uninfected elderly. This elevated CVD risk in PWH is at least partly due
to persistently increased inflammation and activation of CD8 T cells and monocytes that our group has identified
and characterized. Many elderly and nearly all PWH are coinfected with cytomegalovirus (CMV), which we have
shown is associated with inflammation and dramatic expansion of CD8 T cells in PWH, and has been
independently linked to CVD. Activated CD8 T cells accumulate at sites of endothelial dysfunction in vivo,
promote atherosclerotic CVD (ASCVD) in animal models, and can trigger a proatherogenic phenotype on
monocytes in vitro – yet whether CD8 T cells infiltrating the vasculature recognize cognate antigenic peptides
has never been definitively shown in vivo, nor have antigen-nonspecific activating pathways been rigorously
evaluated. In this proposal, we seek to identify how CMV and activated T cells conspire to exacerbate CVD
beyond traditional risk factors in HIV-uninfected persons, and to understand if and how activated T cells further
promote CVD risk in PWH with CMV coinfection. We hypothesize that active CMV replication within
atherosclerotic lesions provides antigen for infiltrating CMV-reactive T cells and that additional antigen-
nonspecific signals (including IL-15 and the CD2/LFA-3 axis) further shape the T cell response. We propose that
these signals exacerbate ASCVD in HIV-uninfected persons and that they are further elevated in those with HIV
infection. We will test these hypotheses with the following specific aims: Aim 1: To define the mechanisms of
plaque CD8 T cell activation in vivo. We will use bulk and single cell RNA-sequencing coupled with barcoded-
antibody and multimer labeling to test the hypothesis that CD8 T cells recovered from atherosclerotic plaques of
CMV+ donors exhibit a more proinflammatory transcriptional program than plaque CD8 T cells from CMV-
donors, and we will identify the activating pathways involved. We will then use immunofluorescence imaging and
fluorescence in situ hybridization to confirm spatial relationships with activating signals such as IL-15, LFA-3,
and CMV. Aim 2: To define the effect of HIV infection on the activation and in situ localization of vascular
CD8 T cells. We will use RNA-sequencing to identify and characterize the mechanisms of activation and antigen-
specificity of vascular CD8 T cells. We will also use immunofluorescence imaging to test the hypothesis that
aortas from PWH will have increased activating signals and additional pro-inflammatory factors that bolster T
cell activation compared to aortas from age- and gender-matched controls. Our studies will define mechanisms
whereby chronic viral infection drives CD8 T cell-mediated vascular pathology and may identify novel targets
beyond traditional risk factors to prevent/treat ASCVD in PWH and the HIV-uninfected elderly.

Public health relevance
PROJECT NARRATIVE Cardiovascular disease (CVD) risk is elevated in persons living with human immunodeficiency virus (HIV) infection (PWH), even when HIV replication is suppressed with highly active combination antiretroviral therapy (ART), and PWH harbor increased inflammation and an associated expansion of circulating activated monocytes and vascular-homing CD8 T cells, particularly in people coinfected with cytomegalovirus (CMV). Activated CD8 T cells are key players in the development of CVD, yet how CD8 T cells are expanded, activated, and contribute to CVD risk in ART-treated HIV infection and in the HIV-uninfected elderly is currently unclear. This proposal will utilize innovative single-cell analysis of vascular CD8 T cells coupled with imaging of vascular tissue specimens from human donors with and without HIV infection to identify how these cells are activated, with a particular focus on CMV antigenic signals, and two antigen-nonspecific mechanisms.